Loss of VCP Function in Frontotemporal Lobar Degeneration

Rare genetic causes of human disease have the potential to reveal mechanistic insights into more
common sporadic disease. Tauopathies are a group of fatal neurologic diseases, including Alzheimer's disease,
where dementia and neurodegeneration are the result of accumulation of pathologic tau protein aggregates in
the form of neurofibrillary tangles, Pick bodies, or glial inclusions. We have identified a novel autosomal
dominant form of frontotemporal dementia with tau inclusions associated with a novel hypomorphic genetic
mutation in VCP which may be linked to a loss of anti-tau disaggregase activity. However, hypermorphic VCP
mutations cause a distinct disease called multisystem proteinopathy which can manifest as frontotemporal
lobar degeneration with TDP-43 inclusions. We propose three specific aims to understand the basic molecular
mechanisms by which this gene mutation leads to diverse pathologies. We will perform structural biology
studies to better understand how VCP protein interacts with pathologic protein aggregates, and how VCP
mutations affect disaggregase activity. We will extend these studies into cellular/neuronal VCP knock-in
models to determine how VCP mutations affect cellular VCP activity within a cellular context. Finally, we will
determine whether gains or losses of VCP activity can modify tau toxicity in vivo. Together, these mechanistic
studies will elucidate basic mechanisms by which VCP dysfunction leads to different types of proteinopathy,
providing the basis for future novel anti-tau therapies based on modulating VCP activity.

Public health relevance
We have identified a new form of dementing brain disease called “vacuolar tauopathy.” While this disease is distinct, the pathologic changes in this rare disease are similar to those seen in Alzheimer's disease. This project will study the basic mechanisms by which a gene mutation leads to the pathologies observed in this and related forms of dementia, providing insights into pathologic changes common to many dementias.